Targeting protein secretion in Mycobacterium tuberculosis

Project Summary
Tuberculosis (TB) remains a major global health burden. In 2021, the number of deaths from TB increased to
1.6 million, once again making it the leading cause of death from infectious disease. Current anti-tubercular
drugs are mainly effective against metabolically active and replicating bacteria. In addition to the need for new
antibiotics that are effective against both drug sensitive and drug resistant strains, there is an urgent need for
new therapeutics that can shorten therapy.
We identified several series of molecules using a target-based, high-throughput, phenotypic screen for inhibitors
of protein secretion. We evaluated these series for tractability and druglike properties and completed preliminary
structure-activity relationship (SAR) studies. We identified two high priority series for hit-to-lead progression. Our
data suggest these molecules target protein synthesis and importantly, have activity against both replicating and
non-replicating bacteria.
The aim of this proposal is to develop new anti-tubercular drugs that work by targeting protein secretion and to
determine the mechanism by which these agents kill Mycobacterium tuberculosis. We will complete lead
generation for our priority series and generate proof of concept of in vivo efficacy in the mouse model of infection.
We will determine how inhibition of LepB-mediated secretion leads to rapid cell death in M. tuberculosis, and
why this is more pronounced under non-replicating conditions. In addition, we will determine the in vitro and in
vivo mechanisms of resistance to LepB inhibitors that will be relevant in the clinical setting.
The outcomes of this project would be (i) identification of a molecule for lead optimization; (ii) identification of the
mode of action and mechanism of kill of the series; and (iii) identification of in vitro and in vivo mechanism(s) of
resistance. Demonstration of in vivo activity and tractability of the series would lead to a full drug development
project in the future.

Public health relevance
NARRATIVE Tuberculosis, caused by Mycobacterium tuberculosis, remains a major global health problem with >1.6 million deaths annually. Our overall aim is to develop new anti-tubercular drugs that combat resistance and shorten therapy. In this proposal we will develop novel inhibitors of protein secretion, determine their mode of action, and determine their resistance mechanism(s).